Endovascular Filtration to Change Drug Biodistribution (ELOCUTION)

PROJECT SUMMARY
We are developing novel minimally invasive catheter-based devices placed under real-time x-ray angiography guidance:
functional endovascular filters that remove chemotherapy from the blood in order to reduce systemic toxicity during
locoregional infusion therapy. The fundamental challenge of eliminating a specific agent from the blood in veins draining an
organ undergoing intraarterial chemotherapy (IAC)—after the agent has its therapeutic effect in the treated organ and before
it causes a systemic toxic effect—can be met by capture strategies based on physicochemical properties of the target agent.
Preclinical ChemoFilter devices containing ion exchange resins (IER) that reduce doxorubicin (Dox) deposition in the heart
of a hepatic IAC swine model by 46% are now being commercialized through startup company Filtro.
We will use advanced imaging to quantify the degree to which venous drug filtration changes the biodistribution of
target drugs infused into the hepatic artery and the carotid artery (with and without blood brain barrier disruption), simulating
the treatment of liver tumors and brain tumors, respectively. Prototype ChemoFilters will be modeled, built, validated in vitro
for efficacy, and tested in vivo for efficacy and safety. Experienced teams from UCSF, Penn State, and Purdue will undertake
the following specific aims: (SA1) mathematically model drug capture by ChemoFilters, (SA2) synthesize radiolabeled
chemotherapeutic analog tracers, (SA3) validate ChemoFilter designs in vitro for capacity to capture drugs, and (SA4) assess
safety and efficacy of optimized filters in vivo in small and large animal models. Achievement of these aims will create a family
of minimally invasive medical devices that could markedly increase the efficacy of image-guided locoregional intraarterial
chemotherapy by lowering systemic drug concentrations and reducing systemic toxicities, thus permitting dose escalation in
any given IAC procedure and better local tumor control in fewer IAC sessions. The imaging techniques developed herein will
enable superior drug distribution monitoring, providing insight into modifying biodistribution clinically.

Public health relevance
PROJECT NARRATIVE We propose a paradigm shift in cancer therapy: ChemoFilter, an endovascular catheter-based medical device that will be inserted under image guidance into the veins of the body to directly filter specific chemotherapy drugs out of the blood stream after these drugs have had their effect on a tumor but before they have caused systemic toxic effects. ChemoFilter would help patients fight cancer by minimizing drug toxicity, allowing for high-dose therapy to better treat their disease and improve survival. This project will develop robust drug absorption predictive models validated through flow model and imaging-based in vivo biodistribution studies, enabling real-time drug distribution monitoring and providing insight into device-medicated biodistribution modification.